Next Generation Sequencing Core (NGS)

PROJECT SUMMARY – NEXT GENERATION SEQUENCING
The mission of the Next Generation Sequencing (NGS) Shared Resource of the Salk Cancer Center (SCC) is to
provide integrated state-of-the-art genomics support for cancer research spanning basic and translational
science. NGS members work with investigators on the design, conduct, analysis, and reporting of cancer
research. SCC recruited Elsa Molina, PhD, as NGS Director with support from the SCC Deputy Director for
Translation Ronald EvansIMT as Faculty Supervisor. During the current grant period, 29 SCC members utilized
the NGS, resulting directly in more than 67 publications.
The mission of the Next Generation Sequencing (NGS) Shared Resource is to facilitate cutting-edge genomics
research at the Salk Institute by:
1) Providing cost-effective, rapid high-throughput, and state-of-the-art genomics instrumentation and
services
2) Providing expert assistance and custom solutions in study design
3) Preparing sequencing libraries, including bulk and single-cell, and performing quality control to ensure
that high-quality data are extracted from each experimental sample
4) Providing digital gene expression assay services
5) Providing whole tissue spatial transcriptomics services
6) Developing novel methods to enable cutting edge genomics technologies
The NGS Shared Resource is committed to bringing novel genomics technologies to its core as well as
embracing new and specific skills to best help SCC investigators with their research needs to successfully
achieve their research goal.